Function and Regulation of Lysine Methylation Dependent Proteolysis

Project Summary
Emerging evidence indicates that many non-histone proteins can be lysine methylated and our
studies have shown that addition of a methyl group to a specific lysine residue in non-histone
proteins leads to the rapid proteolysis of the modified proteins by ubiquitin dependent proteolysis.
We propose to investigate the mechanism by which the methylated proteins are proteolyzed by
ubiquitin dependent proteolysis. Two classes of methyltransferases, SETD7 and KMT2/MLL
family members, can methylate non-histone proteins and the methylated lysine residues in target
proteins serve as the signals for proteolysis. We have identified multiple methyl lysine reader
proteins and two independent ubiquitin ligase complexes for the proteolysis of methylated protein
substrates. The substrate proteins regulate a wide variety of important biological processes
including the control of various stem cells/progenitor cells including embryonic stem cells, neural
stem cells, and hematopoietic stem cells, epigenetic regulation of histone and DNA methylation,
and ATP dependent chromatin remodeling during embryonic and adult development. Alterations
of these important biological processes lead to cancers and other disorders. Since lysine
methylation dependent proteolysis is a new research area, we propose to systematically
investigate the mechanism by which target proteins are modified and proteolyzed by lysine
methylation to establish a new paradigm that controls the self-renewal and differentiation of
different types of stem cells, development, cancers and other disorders. Our specific aims are: 1)
To investigate the dynamic methylation/demethylation mechanism for proteolysis; 2) To examine
how specific ubiquitin ligase complexes cooperate the methyl reader proteins to interact with the
methylated substrates for proteolysis; 3) To develop animal models to investigate the significance
of methylation dependent proteolysis. Elucidation of the proposed research will help understand
how the dose dependent protein regulation and cell fate determination are regulated in various
stem/progenitor and related cells during development and will help to understand pathological
alterations in the methylation dependent proteolysis pathways that should shed new lights for the
development of novel therapeutic strategies for various human diseases such as cancers and
other developmental disorders.

Public health relevance
Project Narrative Emerging evidence indicates that many non-histone proteins are methylated on lysine residues within the H3K4-like methylation motifs by SETD7 and KMT2/MLL methyltransferases but how these methylated proteins are recognized and processed remain largely uncharacterized. We have found that several lysine methylated proteins, such as DNMT1, E2F1, SOX2, EZH2, and components of the mammalian ATP dependent chromatin remodeling SWI/SNF complexes, are recognized by methyl lysine reader proteins to initiate their proteolytic degradation through the ubiquitin dependent process. We propose to characterize the methylation motifs, the enzymes and proteins that catalyze the methylation of lysine residues in proteins and processed the modified proteins for proteolysis to establish a novel paradigm that controls stem/progenitor cells, development, tumorigenesis and other human disorders for therapeutic intervention.